Continuous monitoring of epidermal inflammatory response to mechanical strain

Project Summary
Psoriasis is a debilitating autoimmune skin disease that affects more than 125 million adults globally. While
prototypically associated with immune cell infiltration in the skin, psoriasis preferentially affects the extensor
surfaces of the joints such as the outside of the elbows and knees. Current treatments for psoriasis include
topical steroids, which have poor side-effect profiles with long-term use, and systemic immunomodulatory
agents, which, although promising, have notable off-target immune effects. Better understanding of the nature
of inflammation in the skin may help to develop more precisely targeted therapeutics for psoriasis and associated
disorders. The epidermis of the skin, chiefly composed of keratinocytes, provides an essential barrier between
the organism and the environment. Mechanical disruption of the barrier is associated with development of lesions
in psoriasis and associated disorders; however, it isn’t understood how barrier disruption vs. mechanical
sensation of strain by keratinocytes contributes to their development of psoriatic phenotype. While canonical
inflammatory cells are the drivers of acute inflammation in psoriasis, their action depends on a receptive
environment built up by keratinocyte signaling and behavior. In addition, there is evidence that keratinocyte
autoregulatory loops may establish that autoimmune-prone environment prior to stimulation by canonical
immune cells. As mechanosensing cells at the skin barrier, keratinocytes are uniquely privileged in the
information available to them—unlike canonical immune cells, they have access to both mechanical stimuli and
direct exposure to the status of the epidermal barrier. In this way, keratinocytes are critical messengers of
mechanical and physical barrier status. However, it is difficult to tease apart contributions to inflammation, as
there is currently no method for continuously monitoring inflammatory markers at minute resolution. Furthermore,
there is currently no system for applying physiologic strain to 3D models of psoriasis in vitro. The technology
development portion of this proposal is to design such a continuous monitoring device and develop a system for
applying strain to 3D models of keratinocytes. This proposal will build the tools necessary to test the
hypothesis that keratinocyte mechanosensing modulates their inflammatory behavior in psoriasis. In
Aim 1, I will optimize and validate reagentless sensing devices for continuous monitoring of immunoregulatory
cytokines released by keratinocytes. This aim will seek to understand what events happen on the minute-to-
minute scale as keratinocytes experience mechanical strain. In Aim 2, I will build a novel tissue culture system
for applying controlled strains and measuring mechanical properties of 3D human skin models. In this aim I will
visualize the effect of strain on cytoskeletal and extracellular matrix mechanics, and determine how applied
strains change the threshold for autoimmune activation of keratinocytes.

Public health relevance
Project Narrative Psoriasis is a common, challenging systemic autoimmune condition that most visibly affects the skin, and in particular surfaces subject to regular stretch. This project aims to understand what makes psoriasis particularly target these areas and to better understand how the immune system and skin coexist and work together to protect the body, and how that collaboration can derail into autoimmunity.